Cilia-specific cAMP plays a major role in aneurysm

PROJECT DESCRIPTION
Cyclic adenosine monophosphate (cAMP) signaling regulates diverse pathways and cellular functions that result
in specific responses when compartmentalized. However, the role of cAMP in cilia function is poorly understood,
despite the implication of cAMP in the development of ciliopathies. Using two novel techniques, nanoparticle
drug delivery and a single-cell imaging system, our preliminary data indicate that changes in cAMP within a
cilium could be independent from those in the cytosol. Furthermore, we have preliminary evidence that inhibition
of phosphodiesterase-3 (PDE3), an inactivator of cAMP, can restore ciliary function in ciliopathy models that are
prone to aneurysm, and that aneurysmal vessels are characterized by genomic instability. Here, we hypothesize
that ciliary cAMP plays an important role in aneurysm formation, and we propose to test if PDE3 is involved in
vascular aneurysm via genomic instability (Aim 1) and clarify its role in cAMP signaling in primary cilia (Aim
2). Overall, we will test the idea if a single cilium could be a critical sensor acting as a responsive PDE/cAMP
compartment.

Public health relevance
PUBLIC HEALTH RELEVANCE: No treatment for the vascular malformation seen in aneurysm currently exists. Our studies will examine how a cilium, a small compartment within a single cell, potentially plays a role in vascular aneurysm.